Regenerative Musculoskeletal Medicine Training Program

Abstract
The objective of this renewal application is to support years 16-20 of our current NIAMS T32, “Regenerative
Musculoskeletal Medicine Training Program”, now in its 13th year. Under the astute guidance of our External
Advisory Board (last meeting May 1,2024), the rationale for our T32 is to provide annually six (5 from the grant)
multidisciplinary postdoctoral students with a two-year term of early career training in basic, translational and
clinical research in order to produce the next generation of clinician and non-clinician scientists with specific
expertise in the field of regenerative musculoskeletal science. We will employ a diverse, transdisciplinary
training faculty of 48 scientists from >20 different departments in the UCLA Schools of Medicine, Engineering,
Dentistry and College (undergraduate school at UCLA) with funded research programs and an established
track record of teaching and mentoring; the past success of our trainees is boosted by the fact that all
professional schools and the College and are located on a single campus in Westwood, permitting trainees
“walking distance” access to the basic, translational and scientists in their “mentorship bubble”. Our T32 has
garnered strong, ongoing commitments for support from the David Geffen School of Medicine, UCLA College,
Department of Orthopaedic Surgery, the Broad Stem Cell Research Center and California Institute for
Regenerative Medicine. Under the supervision the Internal Advisory Board and 10-member T32 Junior Faculty
Council, trainees and mentors are evaluated annually with an objective, scorable, 360° survey of their joint
career development progress. As our T32 has evolved we have adapted a number of key didactic and hands-
on training vehicles that embrace the tenets of equity, diversity and inclusion, responsible conduct and rigor
and reproducibility in research. Additional learning opportunities in translational orthopaedics, grant/manuscript
writing, laboratory/project management through the use of LearnORS and the UCLA Clinical Translational
Science Institute (CTSI) Training Program in Translational Science. More sophisticated statistics, AI-enhanced
“big data” bioinformatics, especially in the areas of orthopaedic radiomics (a quantitative approach to medical
imaging), applied engineering and stem cell science, have been added over the years. Of particular note has
been the growth and development of our orthopaedic resident surgeon scientist program now in its 8th year.
This NIAMS-sanctioned initiative has supported 15 orthopaedic surgeon residents and witnessed their
matriculation to research intensive fellowship and faculty positions in academic departments of orthopaedic
surgery. New with this year’s application, will be the launch of a pilot program of orthobiologics headlined by
the recently awarded ARPA-H, “Novel Innovations for Tissue Regeneration in Osteoarthritis (NITRO)” program
with investigators at Duke and Harvard, featuring translational preclinical and clinical science around a
placebo-controlled trial of regenerative small molecules, developed in the Lyon’s lab to simultaneously repair
cartilage and bone in human osteoarthritis of the knee.

Public health relevance
Relevance to Public Health The relevance of this training program to the health of Americans is the the need to train the next generation of scientists in regenerative biomedicine and to address a critical shortage of surgeon-scientists. This training includes the application of “cutting edge” strategies to musculoskeletal regenerative medicine and use of a multidisciplinary, team approach to use those strategies from the laboratory to the bedside.